Role of Intraepithelial airway macrophages in lung homeostasis and disease

Project Summary
Candidate: Tristan Kooistra, MD is a physician-scientist at Massachusetts General Hospital (MGH) and
Harvard Medical School (HMS). His post-doctoral research helped define pathologic cell circuits and
interactions in airways of human subjects with asthma. Building on that work, this proposal investigates how
epithelial-derived Notch signals promote maturation of airway macrophages. The short-term goals of this K08
award are to leverage his existing experience in innate immune signaling, type 2 immunity, and 3D imaging
along with new cutting-edge research skills to address the role of Notch activation in airway macrophages and
how this influences allergic responses. Dr. Kooistra’s long-term goal is to lead an independent research
program investigating the role of airway macrophages in inflammatory airway diseases.
Training Activities: Dr. Kooistra will perform the work outlined in this proposal at MGH mentored by Dr.
Benjamin Medoff, an experienced mentor and expert in lung immunology. Drs. Eric Schmidt, Thorsten Mempel,
Alexandra-Chloe Villani, and Carla Kim will serve on his advisory committee to provide further expertise in
intravital microscopy, ‘omics’ methods, 3D co-culture modeling, and mechanisms of pulmonary inflammation.
Dr. Kooistra will also complete didactic courses in immunology, biostatistics, and systems biology research and
will take advantage of the collaborative and rich intellectual environment at MGH and HMS.
Research: Asthma is a common disease resulting from the pathologic activation of multiple cell types within
the conducting airways and is frequently driven by allergic inflammation to environmental antigens.
Identification of immune regulatory pathways driven by cell-cell interactions in the airway mucosa can identify
novel therapeutic targets. Our preliminary data establishes that airway epithelial basal stem cells supply tonic
Notch activation signals to adjacent intraepithelial airway macrophages (IAMs) necessary to maintain their
MHC-II expression. Moreover, depletion of IAMs or blockade of basal cell Notch signals results in reduced
allergic airway inflammation. We hypothesize that Notch signaling from airway epithelial basal stem cells to
IAMs determines IAM activation state and antigen-presenting capabilities to influence downstream T cell
activation. To test this hypothesis, in Aim 1 we will determine how Notch activation influences IAM
functional maturation at homeostasis using transgenic mouse modeling and single-cell RNA sequencing. In
Aim 2 we will characterize the role of IAM Notch activation in the development of allergic airway
inflammation using intravital microscopy and mouse modeling of asthma. We will leverage 3D airway co-
cultures of human airway macrophages to extend these findings into human tissues. By combining murine
models and primary human co-cultures this proposal will provide mechanistic insight into airway immunity with
relevance to asthma as well as critical training for Dr. Kooistra’s development as a successful “bench-to-
bedside” physician-scientist.

Public health relevance
Project Narrative Asthma is a common disease resulting from the pathologic activation of multiple cell types within the conducting airways and is frequently driven by allergic inflammation to environmental antigens. Our preliminary data suggests that airway lining cells can regulate immune responses by influencing the maturation state of airway white blood cells through a signaling pathway called Notch. The proposed work uses advanced mouse models of asthma, cutting-edge microscopy, and novel human culture methods to define the role of Notch activation in airway white blood cells to reveal opportunities for therapeutic intervention.